CRISPR-Cas13 immunity in Listeria seeligeri

ABSTRACT
CRISPR systems are prokaryotic adaptive immune systems that use RNA-guided Cas nucleases to
recognize and destroy bacteriophage nucleic acids containing sequence complementarity to the guide
RNA. CRISPR systems harbored by different bacteria can be extremely diverse and use different
strategies to neutralize infecting phages. CRISPR systems are not well-represented in traditional model
bacteria. As such, their function has typically been studied by heterologous overexpression in E. coli.
Accordingly, we have limited knowledge of the complex interactions that arose from the co-evolution of
CRISPR-Cas systems with their natural hosts and the phages that infect them. Research in my
laboratory focuses on establishing natural models to investigate the interfaces between CRISPR-Cas
immunity, bacterial host physiology, and phage infection. While most of the six CRISPR types use Cas
DNases to recognize and cleave phage DNA, the type VI CRISPR system uses the nuclease Cas13 to
cut RNA instead. I have developed a natural bacterial host of the type VI CRISPR system, Listeria
seeligeri, and a collection of its phages as a tractable model for studying how this system protects
against infection. Once Cas13 engages target viral RNA, it becomes activated as a non-specific RNase,
resulting in widespread cleavage of both phage and bacterial RNA and the abortion of the phage
lifecycle. Thus, infected cells with type VI immunity do not lyse, and fail to produce viral progeny, but
stop growing and become dormant. The goals of this proposal are to (i) determine which transcripts
cleaved by Cas13 trigger entry into dormancy; (ii) understand how L. seeligeri cells survive the dormant
state, and resuscitate themselves once the phage has been eliminated, and (iii) discover and
characterize endogenous regulatory mechanisms controlling Cas13 activity in L. seeligeri and its
phages. The results generated by this research will provide fundamental insights into the molecular
biology of RNA-targeting CRISPR systems and aid in their development as biotechnology tools. Finally,
Cas13-induced cellular dormancy bears similarity to a phenomenon termed persistence, in which
subpopulations of pathogenic bacteria stop growing and become transiently tolerant of bactericidal
antibiotics during human infection. Therefore, the studies proposed here could reveal general
mechanisms by which persistent bacteria survive antibiotic exposure and re-enter the growth cycle,
which would represent attractive targets for therapeutic intervention.

Public health relevance
NARRATIVE CRISPR-Cas systems are diverse bacterial immune systems that provide anti-viral defense, and have been exploited as programmable nucleases for a multitude of biotechnology and disease treatment applications. We will use Listeria seeligeri as a model microbe to investigate the activities of the RNA-targeting CRISPR-Cas13 system in its natural host. The research proposed here will both yield a deeper mechanistic understanding of how these unique CRISPR systems affect their hosts during anti-viral immunity, and also guide the development and application of Cas13-based biotechnologies that benefit human health.